The TELENEO Trial: A Multicenter Trial of Telemedicine for Advanced Neonatal Resuscitations in Community Hospitals

PROJECT SUMMARY
Approximately 10% of neonates require assistance to begin breathing after birth. At-risk neonates, i.e., those
requiring advanced resuscitation due to prematurity, brain injury, or other conditions, are at increased risk of
mortality when born in a hospital without a neonatal intensive care unit (‘outborn’) compared to at-risk neonates
born in a hospital with a NICU (‘inborn’). Furthermore, at-risk outborn neonates are more likely to suffer serious
morbidity, e.g., pneumothorax, severe intraventricular hemorrhage (sIVH), and seizures, and receive
cardiopulmonary resuscitation in the delivery room. We estimate that there are 10,000-15,000 at-risk outborn
neonates each year who experience poorer health outcomes due to their birth location. However, there are
limited strategies to optimize the resuscitation of at-risk neonates born in community hospitals that lack higher
levels of neonatal care. There is a critical need to improve patient-important outcomes for this population. The
overall objectives in this application are to (i) determine the impact of real-time, audio-video telemedicine consults
provided by a neonatologist (termed teleneonatology) on the risk of early mortality and morbidity for at-risk
outborn neonates, and (ii) evaluate the effect of teleneonatology on delivery room care provided to these
neonates. The central hypothesis is that teleneonatology reduces early mortality and morbidity and improves
delivery room care for at-risk outborn neonates. The rationale for this project is that teleneonatology brings
resuscitation expertise to the bedside of at-risk neonates more effectively than a brief telephone consult, which
is the current practice. Through teleneonatology, the neonatologist can visualize the neonate and provide step-
by-step guidance to the community hospital care team. The central hypothesis will be tested by pursuing three
specific aims: 1) Determine the impact of teleneonatology on the risk of early neonatal mortality (death within 7
days), 2) Identify the effect teleneonatology has on the risk of early morbidity (defined as pneumothorax, sIVH,
or seizure during the first 7 days of life), and 3) Evaluate the impact of teleneonatology on delivery room care.
The three aims are embedded into a single prospective, multi-center research trial. With sequential roll-out of
the intervention using a cluster randomized stepped wedge design, neonatologists from four NICU ‘hub’ sites
will provide teleneonatology consults to at-risk outborn neonates born at 27 community hospital ‘spoke’ sites.
Completion of the proposed research will contribute the first-ever, high quality evidence on the impact of
teleneonatology on neonatal health outcomes. The research is innovative because it uses video telemedicine
to connect neonatologists exactly when needed to at-risk outborn neonates in a way that was not previously
possible. This project is significant because it may identify an innovative care model that reduces the long-
standing outcome disparities experienced by at-risk outborn neonates.

Public health relevance
PROJECT NARRATIVE Teleneonatology is an innovative program that uses real-time audio-video telemedicine to connect doctors with expertise in newborn resuscitation with teams caring for at-risk babies born in small, community hospitals. The proposed research is relevant to public health because it will contribute new knowledge about the impact teleneonatology has on early newborn death and disability, and the quality of delivery room care – which are relevant, important patient and family measures for the 10,000-15,000 at-risk newborns each year who experience poorer outcomes because of the current problem. Thus, the project is relevant to the NICHD mission to enhance the lives of newborns and optimize abilities for all, while also addressing the cross-cutting topic of health disparities.